Early life environmental effects: molecular mechanisms and inter-individual variation

Project Summary
Early life environments can have profound and long-lasting effects on human health, yet the mechanistic basis
of these effects remain poorly understood as do the factors that explain inter-individual variation. These gaps in
knowledge severely limit our ability to both predict susceptible individuals and to develop effective intervention
strategies. At the molecular level, early life effects on later life health are thought to be mediated by stable
changes in gene regulation. However, many gene regulatory elements are responsive to environmental stimuli
throughout life, making it challenging to isolate the effects of early life conditions or to understand their stability,
especially when within-lifetime environmental variation is absent or longitudinal data are not available. My
research program aims to overcome these challenges by working with two subsistence-level groups: 1) the
Turkana of Kenya, who are experiencing rapid lifestyle change such that early life and adult conditions are largely
decoupled and 2) the Tsimane of Bolivia, who have been followed longitudinally for decades. In both groups, I
will generate genome-wide gene regulatory datasets (DNA methylation, gene expression) paired with information
on environmental experiences and health, allowing me to identify the mechanisms that embed early life
exposures into lifelong physiology. I will also generate genome-wide genotype data for each individual, in order
to ask whether genetic variation predicts sensitivity versus resilience to early life challenges at the gene
regulatory level. Finally, I will complement this field-based, observational work with lab-based methods capable
of testing for causal connections between 1) DNA methylation and gene expression and 2) genotype and
environmentally-induced gene expression, both in high-throughput. In doing so, this project will uncover the gene
regulatory mechanisms that mediate early life effects on health, as well as the degree to which these
relationships are modified by genetic variation. By working “in the field” and “in the lab”, the proposed work will
inform our understanding of developmental and environmental processes in natural human populations as well
as causal mechanisms. More broadly, the proposed projects will link a major global phenomenon—increasing
urbanization and market-integration—with gene regulatory processes and health in two understudied and
underserved populations (Africans and Amerindians). It will also generate new methods and resources that will
inform our understanding of the general patterns of genotype x environment interactions in human complex traits.

Public health relevance
Project Narrative Challenging physical or social experiences in early life can have long-lasting effects on individual health. The proposed work will leverage two well-established, unique human cohorts as well as new lab-based, experimental assays to investigate the gene regulatory mechanisms that underlie this relationship as well as the genetic factors that predict individual susceptibility versus resilience. In doing so, this work will improve our understanding how early life experiences become “embedded” into lifelong physiology, our appreciation of the role genotype x environment interactions play in this process, and our insight into intervention strategies that are likely to be effective and that appropriately target individuals at high risk of poor outcomes.